Clinical-Translational Studies in Skin, Lung, and Vascular Complications in Systemic Sclerosis

The overall goal of this Center of Research Translation is to utilize biomarker tools and other translational
research observations to discover new therapies for patients with systemic sclerosis (SSc). This goal can be
broken down into four intermediate objectives: understanding pathogenic pathways through translational studies,
identifying informative biomarkers for SSc complications, applying bioinformatics and systems biology
approaches to interpret translational and biomarker data, and developing novel targeted therapeutics. Among
current obstacles to progress in finding new drugs for SSc patients is the continuing limited understanding of
SSc pathogenesis, in part due to its complexity and heterogeneity, and in part due to the lack of good animal
models. The University of Pittsburgh School of Medicine stands in a unique position for informative translational
studies into SSc due to special resources and intellectual talent. It has very large, longitudinal clinical-biological
SSc repositories in rheumatology and pulmonary divisions; it has the only large national experience in single
cell studies in both SSc skin and lungs; it has a strong experience in studying lung proteomics; it has pulmonary
experts in modeling lung disease using in vitro precision cut lung slices and ex vivo lung perfusion; it has a
highly sophisticated program studying pediatric localized scleroderma, as well as pediatric SSc; it has an
experienced and innovative systems biology group; and it has a vigorous drug discovery platform. In Project 1
investigators will expand preliminary observations using single cell RNA-seq, to understand the transcription
factors (TFs) associated with myofibroblast differentiation and discover latent factors/cytokine mediating
macrophage-fibroblast interaction in SSc and pediatric LS. In Project 2 investigators will examine the genomic
and proteomic landscape of patients with SSc-associated interstitial lung disease. Project 2 will also screen
and carry out preclinical studies of Smad3 translocation inhibitors using precision cut lung slices. In Project 3
investigators will study altered platelet energetics and utilize 18F-fluoroglutamine PET imaging to understand
the role of metabolic reprogramming and glutaminolysis in SSc-associated pulmonary arterial hypertension.
Project aims will be supported by two resource cores: a Clinical and Biospecimen Core and a Systems Biology
Core. The former will include collecting comprehensive clinical data, acquiring skin biopsies and lung explant
tissue, and preparing precision cut lung slices. The latter will use a broad range of bioinformatics tools, including
novel methods for detecting stereospecific TF binding sites, and for discovering latent factors mediating cell-
cell interactions in scRNA-seq/multiome datasets. The Systems Biology Core will also synthesize proteomic
and genomic data in project 2, and integrate data from each project and across projects to develop models for
common molecular pathways associated with different disease manifestations. The focus of each of the
projects on different SSc clinical manifestations, mediators of disease, and drug inhibitors will provide a rich,
highly collaborative environment for fundamental discovery within bridging project topics and core resources.

Public health relevance
This Center of Research Translation is focused on understanding the autoimmune disease, systemic sclerosis (SSc) and to better understand the cellular and molecular processes driving this disease when it affects the skin and lungs. Lung complications of SSc are particularly lethal, but recent technological advances are providing new opportunities for understanding the pathologic processes directly from human diseased skin and lung tissues by examining the molecular alterations associated with disease cell-by-cell. Metabolic changes in cells have also recently become better understood to lead to disease and will be investigated in circulating cells known as platelets, as well as through a novel imaging approach. Thus, this Center proposes to better understand the pathogenic pathways driving SSc skin and lung disease through translational studies, identifying informative biomarkers and developing novel targeted therapeutics. The focus of each of the projects on different SSc clinical manifestations, mediators of disease, and drug inhibitors will provide a rich, highly collaborative environment for fundamental discovery within bridging project topics and core resources.